Administrative Core

ADMINISTRATIVE CORE PROJECT SUMMARY/ABSTRACT
The Administrative Core provides coordination and administrative oversight for the Program Project,
“Understanding Integration in Oncology Care and Association with Quality and Outcomes.”
The Core is housed within the Department of Health Care Policy at Harvard Medical School, which has a long
and successful history of managing large and highly complex research projects. The goals of the
Administrative Core are to coordinate project activities within and between Projects and Cores and to maximize
the Project Leaders’ focus on the scientific work proposed while providing a structure for ongoing evaluation
and critique of the Program Project.
The Administrative Core has two Specific Aims: (1) Provide oversight, administration, and coordination for the
Program Project, including dissemination of findings, and (2) Coordinate project activities, including regular
meetings of the study team and meetings of the External Advisory Board. Major tasks within the first aim
include maintenance of IRB approvals, negotiation, and execution of agreements (Data Use Agreements, in
particular), overseeing data collection activities, recruitment and coordination of staff, procurement of computer
equipment and data, and internal and external project communication. The Core will ensure that diversity,
equity, and inclusion is considered throughout all aspects of the project. Additionally, the Administrative Core
will lead efforts to attract and integrate promising students and post-doctoral fellows to participate in the
research being conducted by the Program Project. Major tasks of the second aim include preparing meeting
materials and agendas, arranging meeting travel and logistics, and carrying out the administrative goals for the
External Advisory Board.
The Administrative Core will oversee and support the achievement of the component research Projects. In
addition, the Administrative Core will lead activities related to dissemination of study results to the public, the
broader research community, and key stakeholders, including clinician leaders, payers, and policymakers.

Public health relevance
PROJECT NARRATIVE: Administrative Core The Administrative Core will oversee and support the achievement of this Program Project, which seeks to examine care integration across four different types of settings and assess how care integration is associated with better care and outcomes for patients with cancer. The Administrative Core will provide oversight and administrative support and will lead activities related to dissemination of study results to the public, the broader research community, and key stakeholders, including patients, clinicians and clinician leaders, payers, and policymakers.